Elucidating the relationship between lipid droplets, oxidative lipid damage, and ferroptosis

PROJECT SUMMARY / ABSTRACT
Cells have evolved intricate quality control systems to prevent the accumulation of aberrant or damaged
macromolecules, such as proteins and DNA. Lipids are chemically diverse macromolecules that have important
functions in membrane biology, energy homeostasis, and signaling. Similar to proteins and DNA, lipids can also
be damaged (e.g., oxidized). However, our understanding of the mechanisms that regulate lipid quality control
remains at an early stage, representing a key gap in knowledge. The accumulation of oxidatively damaged lipids
is a hallmark of ferroptosis, an iron-dependent regulated form of cell death that is an emerging target for the
treatment of drug-resistant cancers. Understanding the regulation of lipid peroxidation and ferroptosis provides
an exceptional system to uncover the mechanisms that govern lipid quality control and to identify novel
therapeutic targets for the treatment of drug-resistant cancers. The prevailing paradigm has focused on the
glutathione-dependent peroxidase GPX4, which suppresses ferroptosis by converting lipid peroxides into non-
toxic lipid alcohols. Employing CRISPR-based genetic screens, we recently discovered FSP1 as a new
ferroptosis resistance factor that acts parallel to GPX4. Mechanistically, FSP1 reduces non-mitochondrial
coenzyme Q10, which functions as a lipophilic antioxidant to suppress the propagation of lipid peroxides. Genetic
disruption or chemical inhibition of FSP1 sensitizes cancer cells of diverse tissue origins to ferroptosis. FSP1 is
present on lipid droplets, the primary lipid storage organelle in cells, but its role on lipid droplets is unknown. The
current proposed research aims to exploit lipidomics, imaging, and biochemically reconstituted and cell-based
assays of FSP1 function to address several outstanding questions regarding the cellular role of FSP1 and its
regulation. In Aim 1, we will test the hypothesis that lipid droplet-localized FSP1 reduces coenzyme Q10 to
prevent oxidation to stored neutral lipids such as triacylglycerol. In Aim 2, we will validate and characterize a
series of regulators that we identified through genetic screens that govern FSP1 post-translational stability. The
completion of these aims will advance our understanding of the mechanisms that mediate cellular lipid quality
control, including determining how neutral lipids stored in LDs are protected from oxidative damage and how
FSP1 levels are regulated in cancer.

Public health relevance
PROJECT NARRATIVE Ferroptosis is a regulated form of cell death that involves the catastrophic accumulation of oxidatively damaged lipids. Targeting ferroptosis is a promising approach to treat drug resistant cancers. Our research aims to understand the cellular roles and regulation of FSP1, a key factor and therapeutic target that promotes cancer resistance to ferroptosis by generating lipid antioxidant molecules.